THE PURPOSE OF THIS TASK ORDER IS TO PROVIDE THE NATIONAL INSTITUTE ON AGING WITH INFORMATION RESOURCE CENTER SERVICES IN ACCORDANCE WITH THE ATTACHED STATEMENT OF WORK AND QUOTE DATED 8/1/2025.

Alzheimer's Disease